CLINICAL TRIAL: A MULTICENTER PHASE 1-2A STUDY OF DIMEBON IN SUBJECTS WITH HUNTI

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. The subproject and investigator (PI) may have received primary funding from another NIH source, and thus could be represented in other CRISP entries. The institution listed is for the Center, which is not necessarily the institution for the investigator. Determine the safety and tolerability of orally administered Dimebon during dosage escalation in subjects with mild to moderate Huntington's disease.